Caring for BRAIN pioneers: Understanding and enhancing family and researcher support in neural device trials

Abstract
The objective of this supplement is to work with members of the BCI Pioneers Coalition, led by
the first implantable BCI study participants, to better understand and promote peer support
structures for BRAIN Pioneers. This proposal expands the neuroethics work being done in grant
1R01MH130457-01, which only looks at support provided by (1) family/care partners and (2)
support provided by researchers. This supplement fills a potential gap in the current R01: How
do research participants support each other? In this study, we: (1) engage with members of the
BCI Pioneers Coalition about best practices to promote peer support for BRAIN Pioneers, using
the World Cafe approach; (2) Jointly synthesize results from World Café meeting with
participants to co-create a set of best practices that promote peer support for BRAIN Pioneers.
This is bioethics research, and also provides capacity building for the MSU junior scholar.

Public health relevance
Project narrative This supplemental grant explores the experiences of and need for peer support for BRAIN Pioneers – people involved in first-in-human or early neurotechnology studies – through partnership with the BCI Pioneers Coalition. Through World Café meetings involving members of the BCI Pioneers Coalition and other neural device users, the aim is to co-create a set of best practices for peer support.